PROJECT 3: Applying Liquid Biopsy Technologies to Detect Clinical Response and Mechanisms of Resistance in the Treatment of LMS

Project 3: Project Summary / Abstract
Leiomyosarcoma (LMS) is an aggressive soft tissue sarcoma (STS) with evidence of smooth muscle
differentiation and is one of the most common STS in adults. Nearly half of patients will develop metastatic
disease either prior to diagnosis or during their clinical care. Chemotherapy is the primary modality for treatment
of metastatic LMS, and the standard chemotherapy regimens use doxorubicin or gemcitabine. These
chemotherapy agents carry a significant risk of toxicity, yet only 15-20% of patients will experience an objective
response and only 5-10% will achieve long-term disease control. The median progression-free survival for
patients with metastatic LMS treated with either doxorubicin or a gemcitabine-based regimen is 6 months.
Despite intensive research efforts to understand the biology of LMS, most studies have been underpowered to
correlate recurrent genomic features at diagnosis with clinical outcomes. Patterns of tumor evolution that give
rise to relapse and chemotherapy resistance have remained unstudied due to the safety concerns associated
with anesthesia and surgery to obtain serial tumor biopsies for research. Newly available liquid biopsy
technologies enable the detection of circulating tumor DNA (ctDNA) in the blood of patients with cancer. In some
malignancies, ctDNA levels correlate with prognosis, and changes in ctDNA levels correspond to disease
response and progression. In Project 3, a prospective collection of blood samples from patients with metastatic
LMS receiving doxorubicin or gemcitabine/docetaxel chemotherapy will be used to study the correlation between
ctDNA levels and clinical outcomes in patients with newly diagnosed metastatic LMS as Aim 1. Data from the
biomarker study will also validate ctDNA as a novel prognostic biomarker. Copy number alterations of genes in
LMS from patients enrolled in the biomarker study in Aim 1 will also be examined as potential prognostic factors
and biomarkers of resistance to front-line chemotherapy. Recent studies show that deep sequencing of ctDNA
can be used as a proxy for sequencing of tumor biopsy samples. Evidence suggests that genomic profiles from
ctDNA better represent genomic heterogeneity in patients with metastatic disease than any single biopsy sample.
In Aim 2, we propose to profile serial ctDNA samples to identify recurrent patterns of tumor heterogeneity and
disease evolution in LMS, and to validate identified acquired genetic changes associated with chemotherapy
resistance using patient-derived xenograft models. These studies will have a major impact on development of a
biomarker for LMS and LMS treatment and will fundamentally broaden the understanding of LMS and the natural
history of this disease. Validation of mechanisms of evolution that give rise to resistant disease could lead to
development of novel therapeutic approaches designed to prevent the emergence of resistance and improve
outcomes for patients with metastatic LMS in the near future.

Public health relevance
Project 3: Project Narrative Leiomyosarcoma (LMS) is an aggressive soft tissue sarcoma that remains difficult to cure even with intensive chemotherapy and surgery. In this study, blood samples from patients with metastatic LMS will be used to profile circulating tumor DNA to identify genomic features that are associated with a high-risk of treatment failure. Results from this study will enable the development of new risk-based and personalized treatment strategies for patients with LMS.